Advancing Insight into Maternal Social Support (AIMSS): Group Prenatal Care and Postpartum Mood

ABSTRACT
Postpartum mood disorders (PPMD) affect 8-13% of new mothers, with another 16-23% experiencing elevated
symptomology throughout the infant’s first year of life. A variety of interventions for PPMD exist, including
pharmacological and psychosocial treatments such as social support. However, existing research on advantages
of social support programs has been limited to the postpartum period only. As such, benefits of social support
programs during pregnancy have not been established, and little is known about the conditions under which
these programs may affect PPMD. CenteringPregnancy is a group-based prenatal care model with demonstrated
positive maternal and infant health outcomes when compared to prenatal care-as-usual (CAU). It addresses
many barriers commonly impeding prenatal mental health interventions, is a low-cost and easily disseminated
model, and has high patient satisfaction across diverse samples. However, documented outcomes are limited to
birth outcomes (e.g., reduced preterm birth rates, reduced low birth-weight, increased breastfeeding) and
prenatal maternal physical health such as gestational diabetes and smoking. The research examining the effect
on postpartum mental health is scant and limited by small sample sizes, absence of postpartum mental health
assessments, and narrow operationalization of mental health outcomes (e.g., depression only). The proposed
project will address these limitations by examining mental health benefits through the following Aims: 1) Use a
newly created, pre-existing dataset (MH126403) for secondary data analysis, to determine under what conditions
the CenteringPregnancy model affects perinatal mental health, delivery outcomes, and early parenting behaviors
compared to CAU prenatal care; 2) Use a qualitative design to better understand particular impacts and
influences of participating in the CenteringPregnancy program on mental health outcomes and early parenting;
and 3) Strengthen Meredith College’s research environment and employ innovative approaches to enhance
existing programs with new and sustainable initiatives to support faculty and student scholarly productivity, and
engage undergraduate research assistants in collaborative research while mentoring and instructing them in
research concepts and processes. This research will contribute to the existing knowledge base by advancing
understanding of social support interventions relevant to maternal mental health and early parenting behaviors,
revealing targeted points of entry for prevention and intervention programs to alter maternal mood disorder risk,
and to promote positive parenting behaviors during pregnancy and throughout the postpartum period.

Public health relevance
NARRATIVE Postpartum mood disorders are the most common complication of childbirth, affecting 10-20% of women with serious consequences to both mother and child. NIMH has identified high priority areas for research on women's mental health during pregnancy and the postpartum period including research on factors associated with PPMD risk or protection, that improves identification and treatment delivery, and deepens the evidence-base for intervention effectiveness.44 This research will contribute to the existing knowledge base by advancing understanding of social support interventions relevant to maternal mental health and early parenting behaviors, revealing targeted points of entry for prevention and intervention programs to alter maternal mood disorder risk, and to promote positive parenting behaviors during pregnancy and throughout the postpartum period.